Cortical control and biomechanics of tongue movement

PROJECT SUMMARY
This research will break new ground in sensorimotor neuroscience by relating cortical and muscle activity data
to shape change in a soft-bodied organ, making it possible to evaluate the generalizability of basic principles of
motor control across musculoskeletal systems. It will develop and test a computational biomechanical model of
tongue function that relates muscle activity to tongue movements, complementing ongoing modeling studies of
human tongues based on more limited kinematic and muscle activity data. By using variation in natural feeding
behavior to elicit a range of hyolingual kinematics, the research will provide insight into the impact of dietary
modification—a treatment for dysphagia—on hyolingual kinematics. This research will lay the groundwork for
development of hyolingual neuroprostheses driven by cortical signals to facilitate chewing and swallowing after
(e.g., cancer) surgery or degenerative diseases, and for better techniques for non-invasive brain stimulation,
muscle stimulation, and rehabilitation exercises used in treatment of, e.g., dysphagia and dysarthria.

Public health relevance
PROJECT NARRATIVE Healthy tongue function is vital for human chewing, swallowing and speaking, and loss of tongue function due to stroke, degenerative diseases and surgery results in significant health problems, including, malnutrition, pneumonia, and difficulty swallowing and speaking. This project will use natural feeding behaviors in nonhuman primates to elicit a wide range of tongue movements and associated muscle and brain activity during chewing and swallowing, develop and test biomechanical models of how tongue movements are produced and how the brain controls those movements. These data will inform strategies for rehabilitation of chewing and swallowing in patients through exercise, non-invasive brain stimulation, lingual prostheses and brain machine interfaces.